Enhancing Loon: Increasing Robustness and Generalizing Input Formats for a Visualization Tool for Large-Scale Microscopy Data

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identiﬁed as NOT-CA-
23-073. Time-series microscopy has important research and clinical applications in cancer, such as selecting the
best drug for a patient. However, time-series microscopy produces very large amounts of data that is difﬁcult
to analyze. It is common that humans need to analyze and review the primary imaging data together with the
output of automatic algorithms for segmentation and tracking, to ensure quality and possibly adjust parameters.
Also, analyzing images and derived data together provides insights beyond simple metrics. To address these
issues, our team has developed Loon, an open source data visualization tool that enables researchers and clinicians
to view and analyze such data at scale. Loon integrates algorithmic results with imaging data, and uses novel
approaches, such as intelligently chosen exemplars, to address the scale issue. As such, Loon has proven an
invaluable resource to our collaborators. However, Loon has been developed as a research project and hence can
only be used with a narrow set of input data. The goal of this project is to harden and improve our software,
leveraging professional software engineering skills and processes, and make it compatible with a wide range
of data formats so that an efﬁcient tool is available to the cancer microscopy community. We will also develop
documentation for developers and end-users, and provide community support. Finally, we will take steps to
ensure that Loon is easy to deploy both locally and in the cloud. We anticipate that our methods and tools will
accelerate and increase the reproducibility of data-driven cancer research.

Public health relevance
PROJECT NARRATIVE Time-series microscopy has important research and clinical applications in cancer, such as selecting the best drug for a patient. We have developed data visualization software that enables researchers and clinicians to view and analyze time-series microscopy data at scale. The goal of this project is to harden and improve our software, and make it compatible with a wide range of data formats so that an efﬁcient tool is available to the cancer microscopy community.